The Epidemiology of the Weiss Cohort Project

PROJECT SUMMARY/ABSTRACT
The goals of this project are to further our understanding of the long-term clinical epidemiology of health
outcomes among drug users who are at high risk for HIV. This is important because it will guide clinical
practice and health systems planning in the face of the continuing HIV/AIDS epidemic and the evolving
epidemic of drug abuse, including opioids. Many HIV-infected persons are living longer than they had in the
past, due to the advent and availability of highly active antiretroviral therapy.
We have a unique prospective cohort of drug users established in the 1980s, backed by a linked biospecimen
repository and permission for indefinite continuing follow-up, established by the NCI and NIDA for the long-
term study of drug users. The cohort numbers nearly 11,000 drug users, who are diverse in gender, race,
ethnicity and geography, and include large numbers of both HIV-positive and HIV-negative persons. Hepatitis
C virus infection is extremely common in these persons.
WE SEEK TO UNDERSTAND THE HEALTH OUTCOMES IN THIS COHORT THROUGH TWO AIMS.
AIM 1. To determine the epidemiologic features of mortality outcomes associated with HIV among drug users
over a 35-year period. This will be accomplished by matching our cohort to vital statistics registry data.
AIM 2. To determine the cancer epidemiology, by cancer site, among drug users over a 35-year period,
including incidence, stage at diagnosis, treatment regimens, mortality, and HIV-associated risk. This will be
accomplished by matching our cohort to cancer registry data.
Our project analyses will integrate these two types of data, with stepwise repetition of matching over several
years. Mortality data will enable us to more accurately conduct survival analyses on an array of disease
outcomes, with a special focus on cancer to identify putative risk factors. This has the potential to assist with
the identification of interventions that would reduce disease burden and prolong survival.
We will characterize disease outcomes in HIV-positive compared to HIV-negative drug users, accounting for
baseline demographic, behavioral, and medical factors. Our cohort uniquely affords the opportunity to study
health outcomes over a prolonged time period spanning several decades in both sexes and in
underrepresented minority populations.
The size of our study and the extent and richness of baseline data will make it a powerful tool in understanding
a wide array of disease outcomes. Given the continuing rapid evolution of biotechnology, future research might
employ evolving biotechnology to use our biospecimen repository to explore specific disease outcomes we will
be identifying. Our cohort has joined the NIDA Genetics Consortium. We will explore joining other consortia
which focus on other outcomes, which could amplify the power of those consortia.

Public health relevance
PROJECT NARRATIVE In the face of the continuing HIV/AIDS epidemic and the evolving epidemics of drug abuse, including opioids, and with many HIV-infected persons living longer, there is a need to have a better understanding of the long-term clinical epidemiology of health outcomes among drug users who are at high risk for HIV. We propose to use the extensive data from our 35-year old prospective cohorts numbering nearly 11,000 drug users, backed by a linked biospecimen repository, and match them to mortality and cancer registry data to characterize disease outcomes in HIV-positive individuals contrasted with such outcomes in HIV-negative individuals, accounting for baseline demographic, behavioral, and medical factors. These cohorts are uniquely diverse in gender, race, ethnicity, and geography, hence affording a distinctive opportunity to study such outcomes in both sexes and in underrepresented minority populations, yielding information that will be of great value in clinical practice and health systems planning.